Core M: HESS

Core M: Health Equity Sociobehavioral Science (HESS) Project
Summary/Abstract
The mission of the Health Equity Sociobehavioral Science (HESS) Core of the SD CFAR is to eliminate HIV
disparities and achieve health equity through social and behavioral HIV research. In order to achieve HIV health
equity, the HESS Core focuses on supporting HIV research with marginalized communities and stigmatized key
populations, including racial and ethnic minorities, sexual and gender minorities, people who use drugs, and
women in sex work.
The specific aims of the Core are to:
1. Research Methods Unit: Promote excellence in social and behavioral HIV science by providing
methodological expertise and services to our Center’s members.
2. Community Engagement Unit: Enhance the involvement of marginalized and underserved communities in
HIV research by providing access to CABs and expertise in participant outreach and academic-community
collaborations.
3. Mentoring Unit: Develop the next generation of health equity HIV investigators by providing mentorship and
training in research methods and community engagement approaches specific to HIV disparities and equity
research.
The HESS Core is the only SD CFAR that provides expertise in sociobehavioral aspects of HIV. Innovations of
the Core, its services, bidirectional community engagement activities, Community Advisory Boards (CABs),
strategic collaborations that advance HIV policy research, and the inclusion of underrepresented minority Core
faculty members who bring diverse cultural expertise enhance the breadth and depth of scientific expertise
provided to SD CFAR members.
Across the Core units – Research Methods, Community Engagement, and Mentoring Units – services include
methodological advisement on sociobehavioral HIV research studies, identification of theory-informed, gender-
affirming, and/or culturally-relevant survey measures and/or interview guides, feedback from the Health Equity
CAB and/or Transgender/Nonbinary CAB, participant recruitment and retention strategies focused on
underserved populations, and mentorship of underrepresented minority early stage investigators. Ultimately, the
HESS Core services and tools can enhance and sustain impact on addressing health disparities among
communities and populations that are marginalized and underserved, and who are in need of solutions to
address social and structural barriers to engagement in HIV testing, treatment, and care.